Targeting EP300, a selective dependency in neuroblastoma

PROJECT DESCRIPTION/ABSTRACT
Despite increases in treatment intensity, children with high-risk neuroblastoma (NB) have poor survival and
significant post-therapy toxicities. The candidate is an Instructor in Pediatrics with 80% protected time for
research who is committed to developing novel therapeutics that are desperately needed to improve the lives of
children with NB. This is a challenge due to the paucity of currently targetable oncogenic mutations in this tumor.
A recent survey identified the histone acetyltransferase (HAT) enzyme EP300, but not its paralog, CBP, as a
selective dependency in NB. This identifies an opportunity to inhibit EP300 without severe toxicity, as CBP may
compensate for EP300 in many normal cells. To this end, the candidate has developed a proteolysis-targeted
chimaera (PROTAC) on-target molecule (“JQAD1”) that degrades EP300 with limited effects on CBP in vitro and
in vivo. JQAD1 causes tumor growth delay in vivo with limited toxicity, and is therefore an excellent starting point
for developing combinatorial strategies for tumor cell killing. Thus, this proposal builds on a strong foundation of
preliminary data to address the central hypothesis that optimized EP300-targeting strategies can be developed
to maximize NB cell death while limiting off-target toxicity using structurally-guided chemical biology with faithful
in vivo NB modeling. This will be pursued in two specific aims: 1) To experimentally determine the most potent
combinations of EP300 degraders and chemotherapies in vitro and in vivo; and 2) To develop improved potency
second-generation JQAD compounds with enhanced on- and off-target specificity. In the first aim, to
appropriately prepare EP300 degraders for clinical use, experiments will identify effective combinations of
conventional chemotherapy agents and JQAD1. The mechanisms of combinatorial compound function, and
tractability of this approach will be established in vitro and in PDX models reflecting the biological and clinical
heterogeneity of NB. In the second aim, second-generation JQAD molecules will be generated using structurally-
based compound development,. These will be tested for effects on EP300 using novel fluorescent in-cell assays,
and in mechanistic assays of EP300 function. This proposal is innovative because it uses mechanistic
approaches involving state-of-the-art gene knockins, compound development and PROTAC technologies to
identify methods to maximize tumor cell death and minimize toxicity. It is significant because targeting EP300
alone represents an ideal strategy to kill NB cells and limit toxicity to normal tissues. This proposal is designed
to provide intensive training and mentoring in chemical biology, animal modeling and experimental therapeutics,
as well as mentoring in grant writing, leadership training and managerial skills, thereby conferring the necessary
skills for an optimal transition to independence. The environment for this proposal is ideal, including scientific
experts necessary to complete this work, a strong institutional commitment and ideal guidance of his mentors,
Drs. Kim Stegmaier and Jun Qi. Thus, this proposal will facilitate his career goals of becoming an independent,
laboratory-based clinician-scientist focused on discovery and therapeutic targeting in cancer.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because studying new chemical and molecular approaches to inhibition of high-risk childhood neuroblastoma may result in novel approaches to treatment of this devastating childhood cancer, as well as other EP300-dependent cancers. The strategy described here, in which existing and newly-generated agents targeting the known neuroblastoma dependency EP300 are assessed alone and in combination with conventional chemotherapy agents is highly relevant to the NCI mission of developing novel therapeutic approaches to advance scientific knowledge, improve survival outcomes and reduce the toxicities of cancer therapy.